Research Administration and Mentoring Core

Research Administration and Mentoring Core Abstract:

The overarching goal of the Research Administration and Mentoring Core (RAMC) is to guide the development of an independent, nationally visible Institute for Biomolecular Targeting (bioMT) at Dartmouth, by fostering continued growth, mentoring junior faculty, further intensifying scientific exchange, and enhancing scientific impact. During phase 1, the RAMC has led the creation of an interwoven and successful environment for research, education, and professional development. In phase 2, it will strengthen the critical mass of the center and lay the foundation for a transition to long-term independence. bioMT will fund four Research Projects, two Scientific Cores, provide supplemental start-up resources for five tenure-track faculty hires, and initiate a formal pilot program in support of research at the basic:translational interface in complex diseases. We will extend and refine our proven faculty mentoring program and will continue to forge a sense of scientific community for all researchers, built around interdisciplinary, curiosity-driven exchanges. By identifying and supporting symbiotic connections between basic science investigations and translational research questions, these components will advance the identification and validation of biomolecular targets to address diseases that affect the health of the American people. Scientific leadership will be provided by Director Dean Madden, PhD, Associate Director Deborah Hogan, PhD, an Internal Advisory Committee, an External Advisory Committee, a Core Advisory Committee, and a Faculty Council. The RAMC will provide efficient scientific leadership, fiscal oversight, and organizational support for all bioMT components. Building on strategies successfully deployed in phase 1, it will achieve the following Specific Aims: (1) To provide outstanding scientific leadership as bioMT members explore new high-impact research directions; (2) To enhance professional skills development through mentoring and educational outreach for all junior faculty; (3) To facilitate robust scientific communication; (4) To offer efficient administrative and fiscal support and evaluation, providing timely and accurate reporting to bioMT and institutional leadership and IDeA Program staff; and (5) To strengthen the research environment using institutional resources. Each of these aims will advance the bioMT mission. Experienced leadership will expand the ability of bioMT faculty to pursue biomolecular target identification, validation, and development. The mentoring program will provide expert guidance to the Project Leaders, accelerating their success as independently funded investigators. A weekly internal seminar series, interspersed with invited talks and the yearly regional Life Sciences Symposium, will catalyze interactions within a highly interdisciplinary scientific team. Our resources will recruit the most highly skilled new faculty to the Institute, elevate their research, and increase their extramural funding success. Program leadership has a strong track record of scientific collaboration and over a decade’s experience with multi-project awards. Drawing on that experience, the RAMC will continue to offer excellent organizational support to the investigators of bioMT and to advancing its success as a Center of Biomedical Research Excellence at Dartmouth.